Quality by Design of orally inhaled drug products: Chemistry, Manufacturing and C

There are many scientific challenges that need to be overcome to manufacture carrier based dry powder inhaler (DPI) products that are safe and therapeutic for treating respiratory diseases. Of these, controlling the manufacture and critical quality attributes (CQAs) of raw materials (both the active pharmaceutical ingredient and excipients) is critical to the successful development of a safe and efficacious DPI product. In this proposal, we seek to determine how primary crystallization and secondary processing of APIs directly influence formulation structure and product functionality of single component and combination based DPI products. The major research objective is to identify and provide a science based understanding of the CQAs of primary and secondary processed APIs. A greater understanding of this relationship between primary crystallization, its CQAs and their influence on surface interfacial properties of micronized APIs, will provide the necessary science and tools to enable greater control of product safety, efficacy, potency, quality and performance. The exploration into the relationship between the physicochemical properties of primary crystals, surface interfacial properties of secondary processed micronized API and the CQAs of these particles will aid the FDA to direct both brand and generic industries to define quality and functionality in DPI drug products.

Public health relevance
Narrative This project addresses several issues of critical importance in regulatory science of carrier based dry powder inhaler formulations. These include how primary crystallization of active pharmaceutical ingredients (APIs) and their critical quality attributes influence final product quality and performance, how the consistency and critical quality attributes of the micronized API is dependent on the manufacturing of the primary API source, and how dynamic changes in the the surface interfacial properties of APIs post-micronizaiton requires an understanding of the requirements for laagering and quarantining of micronized APIs. These studies will show the use and merits of specific analytical tools to measure unique physicochemical, mechanical and interfacial properties and provide the relevant guidance to both brand and generic industries in advancing quality by design approaches for product development and quality control of DPI products.